Administrative Core

PROJECT SUMMARY
The Administrative Core (Core A), led by Dr. Hefty (PI) and working with the co-Investigator, Program Manager,
Core Directors and Leaders, Project Investigators, Mentors, and KU professional staff will; 1) provide scientific
leadership, administration, support for CBID Research and Pilot Projects, Research Cores, and all associated
scientists to best enable their successes and sustainability, 2) establish milestones and implement formative and
summative evaluation strategies to actively mentor program scientists, 3) ensure the optimal selection and
replacement of Research or Pilot Projects and Scientists, and 4) provide development and outreach opportunities
for CBID Center scientists. Formal and informal reviews of the center and center projects will be accomplished
in coordination with a distinguished External Advisory Committee, who will also work with the PI and co-I, to
monitor progress metrics and provide guidance as to overall scientific direction for the cores. All fiduciary matters
related to the CBID and program reporting will be managed by Core A, working with grant management
professionals in KU Shared Services Center, Office of Research, and the Higuchi Biosciences Center.